Innate Recognition of Allogeneic Non-Self

Abstract
Despite significant reduction in acute rejection rates, long-term allograft survival remains
stagnant, hovering at around a half-life of 10 years for most transplanted organs. A principal
cause of poor long-term graft outcomes is persistent host immune activation leading to chronic
rejection. We propose here that persistent immune activation is driven by the innate immune
system, specifically by monocytes which recognize allogeneic non-self and acquire memory to
it. Monocytes sense non-MHC and MHC polymorphisms on allogeneic tissues and acquire the
ability to mount an enhanced recall response specific to donor MHC. This response results in
sustained graft infiltration by mature, IL-12+, monocyte-derived DCs that maintain an
inflammatory Th1 response and are critical for allograft rejection. The goal of this grant
application is to investigate in Aim 1 the molecular and cellular mechanisms of monocyte
memory generation and specificity to allogeneic MHC, and to determine in Aim 2 the
contribution of monocyte memory to chronic allograft rejection. Completion of the proposed
studies is likely to have a significant impact on organ transplantation by uncovering novel innate
immune system targets to prevent or treat rejection.

Public health relevance
Narrative: Despite significant improvement in short-term survival of organ transplants, attrition of transplanted organs over time remains a significant clinical problem. Identifying the mechanisms by which the innate immune system recognizes transplanted organs as foreign and generates memory to them could lead to novel therapies that enhance long-term graft and patient survival after transplantation. !